Multimodal iterative sequencing of cancer genomes and single tumor cells

ABSTRACT
Genome sequencing technology has been transformative in the analysis of cancer. From genomic,
transcriptomic, and epigenetic data, researchers are making new discoveries about the mechanisms of cancer
development that are leading to new therapies and diagnostic tests. Accelerating these discoveries, genomic
analysis is being applied to a wide variety of analytes such as cell-­free DNA and single cells from tissue biopsies.
However, given the increasing range of available genomic sequencing assays available for cancer genomic
studies, a major challenge comes from the limited amounts of clinical tumor samples. Tissue biopsies and
samples oftentimes provide a small amount of genomic analyte. As a result, only one or two genomic sequencing
experiments can be performed, which leads to a less than complete picture of features of a patient tumor.
To address this issue, we developed and validated a technology called APEX – this sequencing technology
enables repeated use of the same nucleic acid analytes derived from a variety of clinical samples relevant for
cancer translational research and clinical studies. As a result, researchers have the opportunity to conduct many
types of genomic analyses on the same sample and genomic material. APEX technology is based on the
covalent attachment of nucleic acid analytes to a solid support, so that the original genomic material is
permanently retained, can be subject to a variety of sequencing assays and as a result, can be analyzed through
many iterations. The use of multiple iterations also offers an opportunity to improve the delineations of critical
genomic aberrations that occur in only a small fraction of the tumor cells. We propose the development of APEX
for integrated multi-­modal and iterative genomic analyses of primary cancer biopsies and cell free DNA from
patients. Aim 1 focuses on cell-­free DNA analytes, and Aim 2 focuses on single-­cell transcriptome sequencing.
Overall, our proposed APEX technology will broadly impact the field of translational cancer research by
providing a new platform whereby clinical samples can be used as a renewable resource for subsequent genomic
sequencing. It removes constraints afforded by limited amounts of tissue samples from translational clinical
studies. With these improvements, APEX will improve the assessment of somatic genomic alterations in cancer
cells, integration of multi-­modal sequencing technologies, and offer personalized molecular analyses for each
cancer patient.

Public health relevance
NARRATIVE Genomic sequencing technologies have rapidly emerged to enable the identification of markers that can diagnose cancers, identify potential targeted therapies, and predict outcomes for cancer patients. However, tiny amounts of available biopsy material limit the types of genomic analyses that can be performed. Our project solves this limitation by the development of a technology that enables material from clinical biopsies to be used repeatedly without loss, enabling a wide breadth of sequencing analyses can be performed on a patient’s cancer with more accurate results.